Ultra-processed Foods, Diet Quality, and Cardiometabolic Health: An Inter-disciplinary Trans-Atlantic Collaborative Project

Project Summary/Abstract
Ultra-processed foods (UPFs) prevail in the U.S. and account for ~60% total energy consumed by Americans.
Fast-accumulating evidence from epidemiological studies shows unequivocal evidence that total UPF intake is
linked to detrimental health outcomes. In thus far the only randomized, domiciled trial by Hall et al, diets
enriched with UPFs led to excess energy intake and weight gain. Yet, the current knowledge base regarding
UPFs does not address a critical question that whether the UPF intake’s health effects are independent or
driven by diet quality. Indeed, our own work suggests that there is a clear heterogeneity among individual
foods groups within the broad UPF category in terms of associations with cardiometabolic diseases. For
example, sugary drinks, processed meats, ready-to-eat mixed dishes were associated with adverse health
outcomes, whereas the opposite was observed for UPF versions of whole grains, cereals, or yogurt.
Apparently, diet quality and UPF may influence human health independently, although this hypothesis has not
been explicitly examined. To address this critical knowledge gap, in this competing renewal we propose to
accomplish four primary aims: 1) to conduct a 6-week feeding trial for discovering and establishing a
metabolomic signature of improved diet quality measured by the adherence to a healthy plant-based diet index
(hPDI) that de-emphasizes UPFs; 2) to conduct a 4-month feeding trial to compare metabolic health effects
between two hPDIs that emphasize UPFs and non-UPFs, respectively, and to derive a second metabolomic
signature of food processing that is independent of diet quality; 3) to critically evaluate the two signatures and
their individual metabolite components in observational studies in terms of how well they reflect diet quality and
UPF intake; and 4) to examine prospectively the metabolomic signatures and individual metabolites in relation
to coronary heart disease (CHD) in four well-characterized U.S. cohorts of diverse racial/ethnic backgrounds.
These complementary, interdisciplinary, inter-connected projects will be led by an investigator team consisting
of established researchers in the U.S., Ireland, and Northern Ireland with expertise in feeding trials,
metabolomics, biomarker research, chronic disease epidemiology, and bioinformatics. The proposed projects
will be jointly funded, without overlapping jurisdictions, by the NIH, Health Research Board and Science
Foundation Ireland in Republic of Ireland, and the Health and Social Care R&D Division in Northern Ireland
through the US-Ireland R&D Partnership Programme, which has fostered trans-Atlantic collaborations for 17
years. These projects will lead to novel evidence that dissects health impacts by diet quality and UPF intake,
discoveries of novel metabolomic signatures of diet quality and UPF intake, respectively, and valuable data
that link the two signatures and CHD risk in U.S. individuals. This study has a great potential to inform the
development of new dietary guidelines and more precise dietary interventions that target UPF intake for
improving cardiometabolic health.

Public health relevance
Project Narrative/Relevance Ultra-processed foods (UPFs) constitute a single most important source of energy for U.S. diets, although the current evidence does not lead to a clearcut understanding of whether the health effects of UPF intake are independent or driven by diet quality. The proposed investigation aims to generate evidence through inter- connected clinical trials and observational studies for deepening our understanding of health effects by food processing that is independent of diet quality, discovering and critically evaluating objective metabolomic signatures of diet quality and food processing, and examining prospectively the signatures in relation to heart disease risk. The proposed research will yield much-needed, novel evidence that may lead to refined dietary guidelines and precision nutrition strategies that focus on UPF intake for improving cardiometabolic health.